Leveraging human musculoskeletal development to identify causal disease variants

Project Summary/Abstract
There exists a major gap in our knowledge on what genes and regulatory regions control the differences in
skeletal morphology between humans, and our best studied model system, the mouse. This is despite the human
skeletons’ importance to walking/running, tool use, and childbirth, and that congenital, trauma-induced, and
aging diseases of the skeleton are very common. This gap has not been spanned by the recent efforts of large
scale consortia (e.g., ENCODE), which have been generating extensive functional genomics datasets on human
and mouse fetal and adult tissues to shed light on organ biology, but which have neglected the skeleton and its
cell types. Here, we propose to remedy this situation and take a first step to fill the gap in knowledge through our
proposal to conduct targeted studies on the human fetal skeleton, at site-specific anatomical levels, using the
functional genomic techniques of single cell multiomics, to detect expressed transcripts/genes and regulatory
elements per cell for each tissue, and spatial transcriptomics for each anatomical region to detect gene
expression at high definition histologically. Importantly, we will generate transcriptomic and epigenomic maps for
all the large joints in the post-cranial body, which will then be intersected with actual human disease-causing
genetic variation from Genome-wide Association Studies to find causal variants. These will be tested in a high
throughput assay to examine each regulatory variants impacts on gene expression. In Aim 1, single cell
multiomics will be performed on human joints for the shoulder, elbow, wrist, interphalangeal joint of the hand,
ankle, interphalangeal joints of the foot, and lumbar sacral joint to map the transcriptome plus epigenome of
each cell type at each joint. These data will be combined with identical data we generated on the hip and knee,
thus covering all large joints of the post-cranium. All of these datasets are compared across three timepoints to
build human-specific maps, noting similarities and differences in transcriptomic and epigenomic usage, reflecting
differences in the attainment of morphological differences in anatomical regions. In Aim 2, high-definition spatial
transcriptomics will be performed on the same anatomical regions as in Aim 1 on human samples to reconstruct
tissue (histological) level gene expression at single cell resolution. These data are then compared across time-
points to build human-specific maps, noting similarities and differences in genic usage at the cell type, and
anatomical-specific levels. In Aim 3, we propose to use a high throughout reporter assay, called the Massively
Parallel Reporter Assay, to test the regulatory functions of thousands of human variants (involved in normal or
disease biology) residing in musculoskeletal cell type regulatory regions. This approach will generate a
compendium of human regulatory elements with effects on such cell type gene regulation, and in doing so will
shed light on the complex regulatory architecture underlying normal human biology (e.g., the shape of the birth
canal or our bipedal knee) and common human skeletal diseases such hip dysplasia or osteoarthritis.

Public health relevance
Project Narrative When comparing the human skeleton to that of our best studied mammalian model system, the mouse, nearly all skeletal structures are quite different, yet we know very little about how and why humans develop their unique morphologies, especially at the genome-wide molecular level. The proposed research focuses on: 1) detecting all of the important genes and regulatory sequences expressed in different joints at cell-type specific level using single cell multiomics on human fetal tissues (HFT); 2) detecting all of the genes expressed in these cells in a high definition histological assay called spatial transcriptomics in order to pinpoint their locations in developing tissues; and 3) studying the impacts that hundreds of thousands of human variant genetic variants associated with musculoskeletal disease have in altering gene expression in important regulatory sequences identified using single cell multiomics and spatial transcriptomics in humans.